Mechanisms underlying asymmetric rotation and morphogenesis of the midgut

ABSTRACT
The mechanisms discovered through the study of embryogenesis have been fundamental to understanding
disease. We use classic chicken embryology and sophisticated mouse genetics to elucidate how basic cellular
processes define the shape and function of organs. We are most fascinated by left-right (LR) organ asymmetry,
as errors of organ laterality are linked to life-threatening birth defects. The counterclockwise rotation of the gut
is an excellent model to study organ laterality. A critical aspect of this rotation is initiation of a leftward tilt
directed by the master regulator of LR asymmetry, Pitx2. Failure to do so leads to gut malrotation and
catastrophic volvulus in pediatric patients. Whereas rotation forces had long been assumed intrinsic to the gut
tube, we instead discovered that gut rotation is driven by asymmetric deformation of the adjacent dorsal
mesentery (DM) that suspends the gut, and whose cellular architecture is downstream of Pitx2. A key property
of the DM is its exquisite binary organization, with distinct LR compartments that are readily accessible to
genetic manipulation. Cellular and extracellular matrix (ECM) changes in each compartment cause the DM to
deform and tilt the attached gut tube leftward. This critical bias determines gut chirality and frames a model to
explain how LR gene expression is ultimately responsible for changes in cell behavior that initiate asymmetric
organogenesis. The DM is also the sole conduit for blood and lymphatic vessels that serve the gut. We
discovered that Pitx2-dependent mechanisms directing gut tilting are also crucial for patterning the gut
vasculature and provide a mechanism to coordinate these two processes. Whereas most situs-specific
organogenesis depends on Pitx2, mechanistic studies downstream have been hampered by a confounding
“double-right” isomerism in Pitx2 mutants. Whereas Pitx2 expression in all vertebrates is activated by Nodal,
Nodal disappears before asymmetric morphogenesis, leaving unresolved the question of how Pitx2
directs organogenesis. We discovered that Pitx2 expression in the gut is not an extension of previous induction
by Nodal. Instead, we demonstrate that gut rotation requires a “second wave” of Pitx2 that is subject to
mechanoregulation by the latent TGFb, linking LR gene expression to force translation. In aim 1, we determine
the mechanism of Pitx2 dose response during gut, vascular, and lymphatic development and identify two
distinct roles for Pitx2 dependent on its repressive threshold on BMP4 signaling. In aim 2, we define the
molecular mechanism by which the formin Daam2, a Pitx2 target, directs mesenchymal cell polarity, actomyosin
contractile asymmetry, and thereby steers the forces to polarize tilting. In aim 3, we combine cutting-edge physical
measurements of tissue properties with quantitative imaging and computational modeling, to elucidate how
stiffness and force anisotropies drive gut rotation through mechanical feedback. Together, these studies will
significantly advance our understanding of the transcriptional and mechanical control of asymmetric gut and
vascular morphogenesis, a critical step toward improved malrotation diagnostics in newborns.

Public health relevance
PROJECT NARRATIVE Gut malrotation is a birth defect of abnormal intestinal rotation that occurs once in 500 live births, and predisposes affected babies to volvulus, a catastrophic strangulation of the intestine and its blood supply. Making use of the accessibility of the chicken egg, genetic mouse models, and force measurements we have developed the tools to answer fundamental questions surrounding correct gut rotation, focused here on the molecules governing physical forces that shape the intestine and pattern gut vasculature. Our work will reveal how the gut rotates and why this process fails, with the goal to improve diagnosis and increase survival in neonates.